Host genetic determinants regulating susceptibility/resistance to SARS-CoV-2

The ongoing coronavirus disease-2019 (COVID-19) pandemic, caused by a novel coronavirus (CoV) termed
severe acute respiratory syndrome coronavirus-2 (SARS-CoV-2) that is closely related to SARS-CoV, poses a
grave threat to global health, and has devastated societies worldwide. One puzzling aspect of COVID-19 is the
impressive variation in clinical manifestations among infected individuals, from a majority who are asymptomatic
or exhibit mild symptoms to a smaller, largely age-dependent fraction who develop life-threatening conditions.
Unfortunately, knowledge of the underlying biology behind COVID-19 susceptibility is woefully inadequate.
Conceivably, some of the differences are likely the consequence of host genetic factors. Systems genetics using
diverse and replicable cohorts of isogenic mice represents a powerful way to dissect those host genetic
differences that modulate microbial infections. We have recently demonstrated that the two founders of the large
BXD family of mice — C57BL/6J (B6) and DBA/2J (D2), differ substantially in their susceptibility to a mouse-
adapted SARS-CoV, MA15. Following intranasal challenge, D2 develop a more severe disease and support
more prolonged pulmonary viral replication than B6. In preliminary studies, we have observed a similar
phenomenon when comparing aged B6 and D2 mice for infection by a mouse-adapted SARS-CoV-2 virus,
CMA4. These key findings support the practicality of using the BXD family of mice to systemically dissect virus-
host interactions that modulate sensitivity to and disease progression of SARS-CoV or SARS-CoV-2 infection.
We hypothesize that variations in host genetic makeup regulate the host responses to SARS-CoV-2 infection,
thereby imparting differing susceptibility/resistance to and outcome of COVID-19. Two specific aims are
proposed to test this hypothesis. In Aim 1, we will determine the impact of genetic background on SARS-CoV-2
infection in the parental strains and across a subset of ~30 BXDs. We will first define the various phenotypes
associated with disease severity, pathogen load, and innate immune responses that distinguish between aged
B6 and D2 following infection with SARS-CoV-2 CMA4 and B.1.351 (a SARS-CoV-2 patient isolate capable of
replication in wild-type mice), respectively. We will then characterize these measurable disease-state
phenotypes, transcriptome and cytokine profiles across a cohort of aged BXD strains of diverse genotypes. In
Aim 2, we will integrate the phenotypic and transcriptomic datasets from Aim 1 and combine them with the
already acquired genotypes and sequence data for the BXD strains to map genetic loci and define the candidate
genes and molecular networks that regulate SARS-CoV-2 replication and pathogenesis. Data from these studies
will uncover novel insights into age-independent host genetic factors that modulate viral replication and disease
susceptibility during SARS-CoV-2 infection. The new knowledge gained will aid the development of
countermeasures against SARS-CoV-2 and possibly other pathogenic human CoV infections.

Public health relevance
Our studies will unveil critical new knowledge of how variations in host genetic makeup modulate the susceptibility to and disease severity of COVID-19 and may identify novel targets amenable to therapeutic and/or prophylactic interventions for this pressing public health challenge.